Extent of PFAS Contamination Resulting from a Fire at a Hazardous Waste Incinerator in East Liverpool, Ohio

On June 27, 2022, a hazardous waste incinerator in East Liverpool, Ohio, a rural, low-income community, caught fire. The incinerator is one of only eight receiving per- and polyfluoroalkyl substances (PFAS) for incineration and received the most shipments in the past year. PFAS, referred to as “forever chemicals”, represent a large group of synthetic chemicals, including PFOA, PFOS, GenX, and encompass approximately 5000 different compounds. PFAS exposure has been linked with toxic health effects and the consequences of PFAS incineration, including the potential of incomplete combustion, are currently unknown. Due to a longstanding, over 10-year, community-academic partnership with the community, our team had recently characterized PFAS in soil surrounding the incinerator, thereby providing our team with a unique opportunity to determine the impact of the fire on PFAS contamination and the extent of this contamination throughout the community. Through our ongoing research partnerships, we have immediate access to recruiting families in the community to participate in successfully accomplish the following time-sensitive specific aims: Aim 1: Characterize post-fire PFAS soil concentrations at the same locations as previously collected and identify geospatial patterns in concentrations to discern differences pre- and post-fire. Aim 2: Determine the extent of PFAS exposure in the community by measuring PFAS in residential soil, drinking water, household dust, and blood samples from individuals who live in close proximity to the incinerator to begin to identify the route of exposure to PFAS exposure in the community. Aim 3: Engage the community throughout the process. We will work through our existing partnerships to inform residents of the study, host community meetings, and provide report-back materials to both community and individuals. We will also develop a website to keep the community informed about the process. This study will provide key information for community members, regulators, and scientists about community PFAS exposure following a fire disaster at a hazardous waste incinerator.

Public health relevance
Project Narrative This study explores community exposure to per- and polyfluoroalkyl substances (PFAS) following a fire at a nearby hazardous waste incinerator. Community exposure will be determined by analyses of pre- and post-fire soil sampling and engagement of residents in a study to determine their household exposure. This study will provide valuable information for community members, decision-makers, and scientists about community PFAS exposure from incinerators, particularly following a fire disaster.